Hepatic Priming of CD4+ T cells Directs Effective Hepatitis B Virus Immunity

PROJECT SUMMARY/ABSTRACT
Chronic infection with hepatitis B virus (HBV) is a leading global cause of end-stage liver disease and
hepatocellular carcinoma; fatal outcomes that can be prevented when serum hepatitis B surface antigen (HBsAg)
clearance is achieved, which rarely occurs with available treatments. HBsAg seroclearance is therefore the
primary goal for next generation therapies. Whereas most adults who develop acute hepatitis B will clear HBsAg
and produce HBsAg-specific antibodies (HBsAb), most young children and neonates fail to clear HBsAg and
develop life-long infection. Most adults with chronic hepatitis B (CHB) therefore acquired infection in early life
when the antiviral immune response proved ineffective. Understanding the immunologic differences responsible
for the age gradient in HBsAg seroclearance provides a roadmap for identifying therapeutic targets for redirecting
the HBV immune response towards HBsAg seroclearance.
To achieve this objective, I will utilize both a well-established mouse model that recapitulates age-related
serological outcomes observed in human HBV infections as well as already collected cytometry and single cell
RNA sequencing (scRNAseq) data from an antiviral therapy withdrawal clinical trial. By employing these
complementary sources of biological information in direct mouse-human comparison, I have the unique
opportunity to make clinically relevant interrogations into the mechanisms of hepatic antigen presentation and
the activation of CD4+ T cells by hepatic conventional dendritic cell (cDCs) that leads to HBsAg seroclearance.
These studies will also identify and test potential therapeutic targets that alter the hepatic immune priming
environment to augment the rate of HBsAg seroclearance in our mouse model.
My proposal is composed of three specific aims. In Specific Aim 1 I will investigate the role of several co-
stimulatory signaling pathways to an age-dependent capacity of hepatic cDCs to activate CD4+ T cells in vitro.
Also, I will use scRNAseq data to identify transcriptomic differences in antigen presenting cell populations that
are associated with HBsAg seroclearance in both mice and humans. In Specific Aim 2 I will use
immunohistochemistry to image age-dependent immune cell interactions in hepatic tissues of mice and test
whether these differences are indicative of age-dependent differences in T cell trafficking and organization in the
liver parenchyma. Also, I will study CD4+ T cells from both mice and humans responding to HBV to again identify
shared transcriptomic differences associated with HBsAg seroclearance. Finally, in Specific Aim 3, I will attempt
to rescue HBsAg seroclearance by bypassing defects in CD4+ T cell priming or treating mice with agonistic
antibodies that target T cell co-stimulatory pathways identified in our preliminary investigations.
By synergistically analyzing data from our mouse model and human clinical trial, my research aims to provide
comprehensive insights into the intricate immune mechanisms influencing HBV seroclearance. By unraveling
these complexities, I seek to identify promising therapeutic avenues that could pave the way for a clinical cure.

Public health relevance
NARRATIVE Chronic hepatitis B virus infection (CHB) causes almost 1 million deaths annually through chronic liver injury, liver failure, and primary liver cancer. These outcomes can be prevented by clearance of the hepatitis B surface antigen (HBsAg), a clinical cure that is rarely achieved with existing antiviral therapies. Using cross-species analyses of a mouse model that recapitulates human age-dependent differences in hepatitis B virus response and data from an antiviral therapy withdrawal clinical trial, I propose to unravel mechanisms that underpin immune-mediated termination of CHB and identify actionable targets for interventions that change the hepatic immune environment to promote clinical cure.